Role of KLK10 in Endothelial Biology and Atherosclerosis

TITLE: Role of KLK10 in Endothelial Biology and Atherosclerosis PROJECT SUMMARY/ABSTRACT: Atherosclerosis is a chronic inflammatory disease of the arterial blood vessels that underlies the occurrence of heart attack, peripheral artery disease, and ischemic stroke; the leading causes of death worldwide. Currently cholesterol lowering statin drugs and stents are the most commonly used therapies for the prevention and treatment of atherosclerosis, however, despite their success, atherosclerosis is still the leading killer. Therefore, new therapeutics are needed to treat atherosclerosis. It is well known that atherosclerosis preferentially occurs in areas of disturbed blood flow while areas of stable flow are protected from developing atherosclerosis. Therefore, it is my goal to develop novel therapies to prevent and revert atherosclerotic diseases by studying the role of flow-dependent genes during my PhD training. In this grant, I will look to characterize one of the most flow-sensitive proteins, Kallikrein Related Peptidase 10 (KLK10), and its effects on atherosclerosis. KLK10 is a serine protease that has increased expression in endothelial cells under stable blood flow, while being dramatically reduced under disturbed blood flow conditions both in vivo and in vitro. KLK10 may also be important for regulating the development of atherosclerosis. We have preliminary data that KLK10 is able to lower endothelial cell inflammation and permeability, however the mechanism is unclear, and it is not known whether these individual effects lead to an overall anti-atherogenic effect. Based on preliminary data, I hypothesize that KLK10 inhibits endothelial inflammation, permeability, and atherosclerosis by mechanisms dependent on the Protease Activated Receptor 1 and 2 (PAR1 and PAR2) signaling pathway. In Aim 1, I will investigate the mechanisms by which KLK10 inhibits endothelial cell inflammation and permeability in a PAR1- and PAR2- dependent manner. This will involve in vivo and in vitro signaling assays using recombinant KLK10 (rKLK10) and pharmacological inhibitors or siRNAs of KLK10 and PAR1/2, under static and flow conditions. In Aim 2, I will test the ability of KLK10 to decrease atherosclerosis in vivo in a PAR1 and PAR2-dependent manner in vivo. In order to carry out these studies, I will use the Partial Carotid Ligation (PCL) mouse model developed in our lab, which allows us to induce disturbed blood flow and atherosclerosis in vivo. By injecting rKLK10 or KLK10 AAV into PCL mice, I will test whether KLK10 inhibits atherosclerosis progression, in both mice WT mice and mice without PAR1 or PAR2. These aims together will test whether KLK10 has a potential role as a therapeutic protein for the treatment of atherosclerosis. Furthermore, we will be able to delineate one of the key mechanisms underlying the flow-dependent development of atherosclerosis. Through this proposal, I will the obtain the necessary PhD training in mechanical biology and vascular pharmacology that will allow me to achieve my goals of developing and discovering novel therapies as a medical scientist.

Public health relevance
PROJECT NARRATIVE: Atherosclerotic disease such as heart attack and ischemic stroke continue to be the leading cause of death in the US and the world, highlighting the importance of developing additional therapies and a better understanding of the pathogenesis of atherosclerosis. KLK10 is a novel gene that is regulated by blood flow and exercise, but its role in atherosclerosis is unknown. This study could shed light into the underlying mechanisms by which blood flow and exercise regulate vascular biology and disease, while serving to develop KLK10 as a potential therapeutic.